Functional MRI of the human nose: an unprecedented investigational window into the nervous system

ABSTRACT
As the major organ responsible for olfaction and air intake, and thanks to its rich connections to the autonomic
nervous system, the nose plays many pivotal roles for survival. In fact, disruptions in olfaction and autonomic
function are often observed before loss of brain function ensues during the progression of neurodegenerative
diseases such as Parkinson’s disease and Alzheimer’s disease. As such, the nose is being increasingly
recognized as a critical investigational target for understanding the complex functional interactions between
peripheral and central nervous system, identifying mechanisms of action of disease, and even for delivery of
therapeutic interventions. Yet, the characterization of system-wide functional connections between the nose and
the central nervous system is challenged by the lack of neuroimaging methods which detect robust surrogates
of functional activity in the nose. In fact, whereas standard functional MRI techniques are formidable tools for
characterizing function in the brain, they are intrinsically inadequate for detecting functional signals in the nose,
because the susceptibility artefacts originating from the air-tissue interfaces of the nasal cavity destroy magnetic
field uniformity and lead to signal loss with standard fMRI techniques that rely on the use of an echo time (TE).
To overcome the challenges of nose fMRI, in this project we will exploit the resilience to susceptibility
artefacts offered by ultrashort/zero-TE acquisition schemes, which we previously demonstrated being capable
of providing robust fMRI contrast primarily mediated by blood flow. Our pilot data demonstrate that
unprecedented fMRI signals during both tasks and resting state can be detected with ultrashort TE (UTE)
techniques in the human nasal cavity. Therefore, our plan here is to first optimize these innovative UTE protocols
for fMRI of the human nose, and to apply them in cross-sectional and in test-retest studies designed to provide
supporting evidence to our overarching hypothesis: UTE enables detection of robust nose fMRI signals primarily
mediated by blood flow fluctuations that generally correlate with ANS activity and that during the presentation of
odor stimuli specifically reflect olfactory processing in the nose. Protocol optimizations will be first performed to
ensure maximum coverage, functional contrast, spatial and temporal resolutions on each of two clinical MRI
platforms, 7T and 3T. Detection sensitivity and reproducibility of nose fMRI signals and system-wide connections
between nose and the nervous system will be then evaluated on each MRI platform. To determine whether the
fMRI nose signals reflect olfactory processing, we will deliver different sensory stimuli (odor, visual and odorless
airflow stimuli); to characterize the dependence of nose fMRI signals on the function of the autonomic nervous
system, we will correlate the nose fMRI signals with other surrogates of autonomic function such as hearth rate
and breathing rate variabilities. Once completed, this study will have demonstrated the first proof-of-principle use
of nose fMRI in humans by making use of widely available clinical scanners, thus greatly facilitating translational
applications and dissemination to a broad community of researchers and clinicians.

Public health relevance
NARRATIVE The nose plays many pivotal roles for survival, and is a crucial investigational target for research of many diseases as well as for therapeutic interventions. The goal of this project is to establish unique functional MRI (fMRI) capabilities that enable unprecedented measures of nose function and nose functional connections. Nose fMRI will allow uncovering the involvement of nose activity within the function of the nervous system, leading to high impact in basic and clinical research.